Recharge Behavioral Therapy for caregivers of individuals with Alzheimer's Disease

Project Summary
Caring for individuals with Alzheimer's Disease (AD) is associated with depressive symptoms and “burden”
because dealing with AD patient's cognitive, behavioral and personality changes is very challenging and
stressful for caregivers. There are over 11 million AD caregivers in the US, providing informal care services to
family members, with high incidences of stress (59%) and depressive symptoms (30%).
Clinical trials and other academic research demonstrated the benefits of non-pharmacological interventions to
improve the psychological well-being of AD caregivers, however there is a recognized need to translate these
programs to accessible products/services and deliver them widely at minimum cost.
To address these needs, we propose the new Recharge Behavioral Therapy (RBT), derived from an evidence-
based protocol to treat depression (Behavioral Activation) and a proven program to train coping skills (Coping
With Caregiving). We will translate prior research, combine powerful behavioral activation methods, and tailor
the integrated curriculum for AD caregivers into a new intervention to reduce stress and depressive symptoms.
Besides being an effective treatment for depression (efficacy stablished by multiple clinical trials), Behavioral
Activation (BA) was selected because it motivates individuals to engage in healthy behaviors to improve their
wellness. AD caregivers usually sacrifice their own physical and emotional needs, when providing care. The
BA component will encourage caregivers to take care of their own well-being and “Recharge their energy” in
their caregiving journey, so that they can fulfil their caregiver role at their best and improve their quality of life.
Coping With Caregiving (CWC) is a psychoeducational training program for AD caregivers, evaluated in
several clinical trials with demonstrated effectiveness in decreasing caregiver distress, burden of care, stress,
and depression. By integrating CWC in RBT, we will provide the necessary consideration to the AD caregiving
context and the resulting intervention will contain beneficial coping strategies for AD caregivers.
Furthermore, the implementation mechanism for the RBT intervention will be the new Recharge Mobile App
(RMA), an interactive, easy to use, and engaging mobile app that can be deployed to millions of people on
demand (app install from app stores) and at very low cost (small subscription fee).
RMA will be tailored for AD caregivers with training, practices, and content for RBT, which is not available in
the market. Creative use of app features (interactivity, compliance, and notifications) will engage caregivers.
Phase I will determine the initial RBT curriculum, develop the RMA prototype, and evaluate the feasibility.
Phase II will fully develop RBT/RMA and evaluate the intervention effectiveness with a randomized clinical trial.
RMA will help to reduce caregiver stress and depressive symptoms related to AD caregiving with a non-
pharmacological approach; offering an effective, low-cost, and accessible mobile app to be disseminated to
innumerous families struggling with Alzheimer's Disease through Apple and Google Play app stores.

Public health relevance
Public Health Relevance As a large number of informal family caregivers (over 11 million) are at high risk for stress and depressive symptoms related to the difficulties of caring for individuals with Alzheimer's Disease (AD), there is a need for effective, accessible and cost-effective interventions. The new Recharge Behavioral Therapy (delivered by the Recharge Mobile App, RMA) will be an innovative program for teaching Behavioral Activation skills to AD caregivers, motivating healthy behaviors, and improving psychological well-being, which can be deployed widely and at low cost. After Phase II completion, the expected project outcomes are: reduce stress, alleviate depressive symptoms, enhance coping skills, and improve the quality of life of AD caregivers; in addition, the following indirect benefits are expected (not measured by this study): delay patient institutionalization, decrease caregiver medication related to stress/depressive symptoms, and thereby lower economic costs associated with AD caregiving.